Administrative Core

Project Summary/ Abstract
The Center for Addiction and Disease Risk Exacerbation (CADRE) Administrative Core will provide the
scientific leadership and administrative support necessary to ensure the success of this Phase II
COBRE. Thus far, we have made excellent progress in establishing an integrated multidisciplinary
center that fully leverages the resources of Brown University, its affiliated hospitals, and the broader
community, to address the link between substance use and chronic disease. We have successfully
transitioned four of six Project Leads to R01 independence. Our four Admin Core specific aims are:
Specific Aim 1 – To further solidify a team and organizational structure that provides leadership and
administrative support for scientific excellence and facilitating the goals of the CADRE. Specific Aim 2 –
To provide state-of-the-art mentoring support and initiatives for the CADRE PLs and PPLs to facilitate
their success in achieving independent grant funding. Specific Aim 3 - To increase the diversity of the
biomedical workforce and address SU and its effects on health in underserved communities, we will
administer a pilot project program and recruit postdoctoral fellows. Specific Aim 4 – To conduct ongoing
evaluation of the overall CADRE, including its Cores, Research Projects, Pilot Research Projects, on
scientific and career development objectives, so that CADRE is continuously evolving and improving.
In Phase II, we will have a fully engaged five-member Advisory Committee with both disciplinary depth
and breadth, and the support of 28 senior faculty members at Brown and its affiliated hospitals who will
serve as CADRE affiliated scientists. Our choice of Principal Investigator and Deputy Director continue
to be one of our strengths, as both have diverse experience in research, training, and mentoring that
strongly complement one another. Dr. Monti (PI) is a clinical psychologist who has been at Brown for
decades. He directed the Center for Alcohol and Addiction Studies (CAAS) from 2000 to 2022 and was
director of the NIAAA T32 for the past 32 years. Dr. Ahluwalia (Deputy Director and Director, Admin
Core), an NIH funded physician scientist, has been at Brown for six years. While at Univ. of Minnesota,
he was PI of a NIMHD P60 Center of Excellence in Minority Health and associate director of the CTSA.
Both have served on NIH National Advisory Councils, Monti for NIAAA and Ahluwalia for NIMHD.
Brown’s 5-year commitment of $1.375 million will focus on supporting CADRE’s goal of diversifying the
biomedical workforce (postdoctoral fellows from a group underrepresented in biomedical sciences),
and addressing health disparities (ensuring pilot grants program will focus on the higher burden of
substance use and chronic disease among racial and ethnic minorities). With this significant NIH and
institutional investment, we will be able to extend our current work to ensure it propels the careers of
promising early career faculty, diversifies the biomedical workforce, and addresses health disparities.